The Heartland Center for Occupational Health and Safety Education and Research Center

OVERALL – PROJECT SUMMARY/ABSTRACT
Vision and Mission: The vision of the Heartland Center for Occupational Health and Safety (the Heartland
Center) is to be the leading educational and outreach resource for occupational safety and health in the states
of Iowa, Kansas, Missouri and Nebraska (Region VII). The Center’s mission is to reduce injuries, illnesses, and
fatalities of workers by expanding and strengthening the occupational health and safety workforce with well-
trained and well-informed professionals.
Objective: The academic training provided by the Heartland Center will increase the number of highly
knowledgeable and experienced occupational health and safety (OHS) professionals in Federal Region VII
(Iowa, Nebraska, Kansas and Missouri). The Center’s outreach and continuing education programs will
enhance the capabilities of occupational health and safety professionals to reduce the high rates of
occupational disease and injury in this region.
Rationale: The major rationale for the Heartland Center is to satisfy the need for OHS professionals in this
Region, provide practical information for the professional development of OHS professionals in this Region,
and serve as a conduit of OHS-related information to this Region. The Center will consist of 5 graduate level
training programs, including industrial hygiene, occupational safety, ergonomics, agricultural safety and health,
and occupational injury prevention. The Center will also contain active continuing education and outreach
program designed to reach thousands of OHS professionals in the Region using traditional and innovative
distance-education technology and information dissemination techniques. The Center is structured to maximize
its mission with a central administration guided by a strategic plan and input by an active internal and external
advisory board. A strong evaluation plan is used to monitor all aspects of Center effectiveness. A
comprehensive diversity recruitment plan enhances the enrollment of students from underrepresented
populations. The project team is committed to diversity, equity, inclusion and accessibility in all aspects of the
Heartland Center.
Programs: This proposal supports a request for continued funding of the Heartland Center during the period
2024 - 2029. The minimum annual number of trainees in each program area are the following: Industrial
Hygiene - 5 master's, 1 doctoral); Occupational Safety - 3 master's, 1 doctoral; Ergonomics – 2 master’s, 1
doctoral; Agricultural Safety and Health - 2 master's, 2 doctoral; Occupational Injury Prevention - 1 master's, 2
doctoral; Continuing Education (CE) – 1600 participants.

Public health relevance
OVERALL – PROJECT NARRATIVE The Heartland Center for Occupational Safety and Health is well positioned to address the burden of illness and injury to workers in the Midwest by preparing trainees with knowledge and experience in the discipline areas most relevant to the needs of workers in this region. As professionals, these trainees will have a long- standing positive influence on the health and well-being of workers in this region and the rest of the nation.